Dosing and Pilot Efficacy of 2'-Fucosyllactose in Inflammatory Bowel Disease

Crohn’s Disease (CD) is a chronic and debilitating disorder with peak incidence in the second and third
decades of life. While considerable progress has been made in optimizing medications to achieve remission,
relapse is common and unpredictable. Altered microbiota likely drive gut inflammation and clinical relapses.
Microbiota-accessible dietary carbohydrates with beneficial health effects, known as “prebiotics,” hold promise
for restoring healthy gut microbiota in CD and preventing clinical relapse. Here, we propose completion of the
first studies of the prebiotic human milk oligosaccharide, 2’-fucosyllactose (2’-FL), for maintaining remission in
CD. Our overarching hypothesis is that 2’-FL supplementation in CD will be safe and well tolerated, while
increasing fecal Bifidobacterium abundance and butyrate in a dose dependent manner. We will test this
hypothesis by completing a randomized, placebo-controlled dose-ranging study which began enrollment
during the tenure of the current award and includes the following Aims: Aim 1. Define dose dependent
safety and tolerability of 2’-FL as a dietary supplement in CD. We will test 1g or 5g 2’-FL compared to 2
gm dextrose placebo as a daily dietary supplement in pediatric and young adult CD patients in stable remission
receiving infliximab or adalimumab anti-TNF therapy. Safety and tolerability will be assessed using validated
clinical disease activity and gastrointestinal symptom rating indices, and fecal calprotectin. Aim 2. Define
dose dependent efficacy of 2’-FL as a dietary supplement in CD. We will utilize our established fecal
metagenomic and metabolite profiling assays to test the effect of a range of 2’FL doses upon the gut microbial
community and associated metabolic functions with a focus upon butyrate production. Efficacy will be
assessed by determining the dose dependent effect of 2’-FL upon increased fecal Bifidobacterium and butyrate
abundance. We will account for FUT2 secretor status and dietary fiber intake in the analysis. These studies
will have a high impact in the field by providing critical phase I/IIa safety and efficacy data in support of a
phase III RCT using our NIH-supported CD clinical research network to test the efficacy of 2’-FL in directly
modulating beneficial microbiota and thereby enhancing sustained clinical remission and mucosal healing.
Ultimately the proposed studies will promote a fundamental shift in clinical practice towards personalized
microbial therapeutic interventions.

Public health relevance
Altered microbiota drive mucosal inflammation and clinical relapses in patients with Crohn’s Disease (CD). We will complete the first studies of the prebiotic human milk oligosaccharide, 2’-fucosyllactose (2’-FL), for enhancing beneficial microbiota and associated metabolites in CD patients. These studies will have a high impact in the field by providing critical phase I/IIa safety and efficacy data in support of a phase III randomized-controlled trial to test the efficacy of 2’-FL in directly modulating beneficial microbiota and thereby enhancing sustained clinical remission and mucosal healing.